Computational genomics approaches to study mechanisms and function of mRNA splicing

Project Summary
The overarching goal of this project is to understand how RNA splicing is encoded in DNA sequence and how it
impacts biological function and to use this knowledge to help design treatments or drugs to improve human
health. Achieving these goals requires a comprehensive and deep characterization of mRNA splicing
mechanisms and function, which can only be achieved by developing and applying novel genomic assays,
computational approaches, and analytical framework to study mRNA splicing. In this project, we propose to: (i)
develop computational methods to facilitate studies of RNA splicing in human biology and disease, (ii)
characterize splicing-mediated regulation of gene expression levels, which our preliminary findings indicate is a
common mechanism and can redefine our functional view of splicing, (iii) investigate mechanisms of RNA
splicing modulation by small molecules. Our project has the potential to significantly advance our understanding
of RNA splicing mechanisms and function and will help us leverage mRNA splicing as a target for therapies.

Public health relevance
Project Narrative Compared to the vast number of studies on mRNA expression level regulation, there is a paucity of studies on mRNA splicing. We propose to develop multiple computational and genomics approaches to study the function and mechanism of mRNA splicing. Our work aims to have a broad impact in both basic biology and translational medicine.